Transcriptome-scale, condition-specific regulation of mRNA isoform stability via the 3'UTR

Project Summary/Abstract
Altering environmental conditions leads to reprograming of eukaryotic gene expression. One important
cellular process that helps adapt gene expression levels to environmental triggers is the regulation of mRNA
stability. mRNAs are degraded by specialized cellular machineries, which have been studied in great detail.
However, little data exists to explain what cellular signals determine mRNA longevity in response to changing
conditions. Alternative polyadenylation allows an individual gene to give rise to multiple distinct mRNA 3’
isoforms. Distinct 3’ isoforms from the same gene can have different half-lives, and the steady-state distribution
of mRNA 3’ isoforms can vary under different growth conditions. It is plausible that a diverse array of isoforms is
needed for cells to respond to environmental conditions. In part, different isoforms could allow for prompt
modulation of gene expression via regulation of mRNA stability. Until now, there have been no genome-wide
studies addressing the importance of different isoform profiles for mRNA stabilities under different conditions.
This work will comprehensively examine condition-specific isoforms, isoform properties, and cellular factors
involved in the regulation of isoform half-lives. In particular, a catalog of isoform half-lives for different growth
conditions will be obtained using techniques optimized and/or developed in the Struhl laboratory for studying 3’
isoforms. The isoforms will be subsequently examined for sequence and structural elements. The relevance of
any cis-features identified will be directly tested in the context of defective trans-factors, such as degradation
machinery components or putative RNA-binding proteins. The proposed work will advance our understanding of
the molecular mechanisms that underlie regulated mRNA decay by investigating isoform half-lives and
sequence/structural elements under various conditions on a genome-wide scale. The work is expected to reveal
3’ isoform-dependent regulation of mRNA stability by the major degradation pathways and/or RNA-binding
proteins in response to environmental triggers.
Building on the investigator’s background in nuclear proteostasis, training and expertise in genomics and
bioinformatics will be gained. The project will be conducted in a world-renowned transcription group with deep
experience in this field, providing a strong foundation for the applicant’s future independent research as a
principal investigator in the field of gene expression.

Public health relevance
Project Narrative Messenger RNA decay is a central cellular process, and its misregulation leads to numerous diseases. This work addresses mechanisms of mRNA decay and its fundamental role in regulating eukaryotic gene expression. The results will improve our understanding of eukaryotic gene regulation, which is of key importance in human biology and disease.